Discovery of heart-derived myokines mediating the response to exercise stress via PGC-1a

PROJECT SUMMARY
This proposal seeks to support the career development of Dr. Sumeet Khetarpal MD, PhD, a physician-scientist,
cardiology fellow and incoming Instructor at Massachusetts General Hospital (MGH). Dr. Khetarpal seeks ﬁve
years of mentored research support for training in exercise, cardiac metabolism and proteomics to catalyze his
career development as an independent physician-scientist in cardio-metabolic diseases. These diseases are
major causes of death and healthcare costs in the world. While many treatments exist, disease burden remains
high, prompting the need for new approaches to therapy and prevention. Exercise reduces the onset of and
morbidity from many cardiovascular diseases including heart failure. The molecular mediators of exercise that
confer beneﬁcial effects have been poorly deﬁned particularly in the heart. In muscle and adipose tissue, exercise
promotes secretion of proteins that regulate energy balance. A key regulator of this process is the exercise-
induced transcription factor PGC-1α, which governs mitochondrial responses to energy stress. The heart's
adaptation to exercise involves increasing mitochondrial function. However, the role of the heart as a secretory
organ is poorly understood. This proposal tests the hypothesis that heart-secreted proteins (myokines) contribute
importantly to the heart's adaptation to exercise and prevention of heart failure. Initial studies will focus on the
contribution of maladaptive myokines to the development of cardiac atrophy in a mouse model of exercise-
induced heart failure lacking PGC-1α. Subsequent studies will test the ability of one newly identiﬁed PGC-1α-
dependent myokine to mitigate cardiac dysfunction in a model of heart failure. A third effort will identify novel
heart-derived myokines from exercise-trained mice through proteomics of heart extracellular ﬂuid. Collectively
this work will provide an understanding of how endurance exercise modulates heart protein secretion and
generate datasets (the cardiac “secretome” of exercise). This will provide a fundamental platform for the
applicant's transition to independence. Dr. Khetarpal will greatly beneﬁt from primary mentorship by Dr. Bruce
Spiegelman at Harvard Medical School (HMS), a world-leader in molecular metabolism and discovery of novel
metabolically active myokines. Key intellectual co-mentorship in cardiac molecular adaptations to exercise will
be provided by Dr. Anthony Rosenzweig at the University of Michigan. Dr. Khetarpal will also be advised by a
team of cardiovascular physician-scientists at HMS (Dr. Patrick Ellinor and Dr. Jason Roh of MGH and Dr. Aarti
Asnani at Beth Israel). Dr. Khetarpal also has rich support from key HMS collaborators on proteomics (Dr. Steve
Gygi) and lipid metabolism (Dr. Jorge Plutzky) and a deep commitment from MGH and his primary mentor Dr.
Spiegelman at HMS. Through the outlined mentorship and investigation, Dr. Khetarpal will complement his prior
training in human genetics and lipid metabolism to new domains of proteomic screens, mitochondrial metabolism
and cardiac physiology. This will provide an incredibly rich foundation for a successful career as an independent
academic physician-scientist working to reduce cardio-metabolic disease morbidity through molecular discovery.

Public health relevance
PROJECT NARRATIVE Heart diseases are leading causes of death, morbidity and healthcare costs throughout the world. Regular exercise helps reduce the risk of and harms from heart diseases, but the mechanisms behind these beneﬁts are poorly understood. This research proposal will study the heart's response to the stress of exercise and discover new ways the exercising heart may protect from disease by studying the proteins it secretes during exercise and through studying their biological functions.